Novel point-of-care liquid biopsy for early detection of sepsis-associated organ damage

Sepsis, defined as a dysregulated immune response to infection leading to end-organ damage, is a critical
problem that imposes considerable burdens on health care systems globally. However, despite its importance,
sepsis is notoriously challenging to diagnose with precision, since neither infection nor organ dysfunction may
be evident upon initial clinical assessment. Our overall objective in this application is to develop a novel
circulating cellular biomarker for the early detection and assessment of sepsis-induced organ damage. Our team
pioneered the “liquid biopsy” approach to cancer detection and monitoring, and we have recently extended this
approach to systemic infection, detecting circulating lung epithelial cells in severe COVID-19, and
cardiomyocytes in children with cardiac manifestations of multisystem inflammatory syndrome (MIS-C), providing
proof of concept for extending our approach to infectious diseases. Our central hypothesis is that the detection
of tissue-derived circulating rare cells (tCRCs, e.g. cells originating from the lungs, kidney, etc.) in the peripheral
blood of sepsis patients will serve as a measurement of early organ/tissue damage to enable early diagnosis
and monitoring of patients. The ability to noninvasively sample tissues affected by sepsis, COVID-19 and
hyperinflammatory sequelae such as MIS-C, and ultimately other systemic infectious or inflammatory syndromes
may both (1) clarify diagnosis of these syndromes that often lack specific diagnostic criteria or tests and (2)
provide important insights into disease mechanisms, tropisms, and treatment response. To minimize one source
of heterogeneity (anatomical source of infection) in this pilot study of a notoriously heterogeneous clinical
syndrome, we will limit enrollment to sepsis of suspected pulmonary source.
We propose two specific aims: In Aim 1, we propose to optimize a microfluidic enrichment and droplet-
based digital PCR (ddPCR) assay to detect tCRCs first in spike-in samples, then in a series of 60 patients with
pneumonia at risk for sepsis (n = 30 adjudicated to have sepsis, and 30 without). In Aim 2, we will identify tCRC
transcriptional signatures for early detection of sepsis-induced organ damage via bulk (n = 60) and single-cell (n
= 15) RNA-Seq. We will use patient enrollment criteria that we have successfully used in prior studies of sepsis.
The proposed research is innovative because our approach has the potential to fill the significant gaps in
(1) diagnosis and monitoring of disease progression and treatment response via non-invasive methods (i.e.,
liquid biopsy) with high sensitivity and specificity, and (2) early, non-invasive pathophysiological characterization
of sepsis and potentially other inflammatory conditions. The project is significant because it has the potential to
provide a blood-based cellular biomarker for a common and critical illness, via an approach that can potentially
extend to other systemic diseases. Ultimately, building upon this pilot proposal, we anticipate in the longer term
that this novel approach can offer a novel diagnostic tool to non-invasively sample end-organs affected by
systemic infection, just as circulating tumor cell detection has revolutionized the detection of cancer metastasis.

Public health relevance
There is an urgent need for sepsis biomarkers for early detection and assessing the extent of organ dysfunction. We helped develop the technology underpinning “liquid biopsies” of circulating tumor cells for non-invasive detection of metastatic cancer, and we have shown in preliminary studies that we can adapt this technology to profile systemic infections. We propose to develop a blood-based analysis for early detection of sepsis and non-invasive assessment of sepsis-induced organ damage.